Continued Enhancement of the WDA Manufactured Food Regulatory Program Standards to Ensure Sustainability

PROJECT SUMMARY/ABSTRACT
The project “Continued Enhancement of the WDA Manufactured Food Regulatory Program
Standards to Ensure Sustainability” is designed to ensure that the Wyoming Department of
Agriculture, Consumer Health Services (WDA/CHS) continues to improve the state’s
Manufactured Food Program. WDA/CHS has been in full implementation and full conformance
with all ten standards since 2017.
This project will address four (4) main goals.
The first goal of this project is to ensure inspectors are adequately trained. This goal will ensure
that WDA/CHS has the funding and personnel to continue to meet the Manufactured Food
Regulatory Program Standards (MFRPS) and be part of an Integrated Food Safety System.
The second goal of this project is to continually evaluate and implement Program Development.
This includes reassessing the risk factor criteria used to determine risk assessments of facilities;
continue utilizing the NFXDS system; evaluate state program equivalency status as compared
to federal regulation and determine if regulation needs to be incorporated into state rule; expand
and strengthen the state's Preventive Controls (PC) Program; equip staff to conduct all facets of
their position and increase the scope of the sampling program with the Wyoming Department of
Agriculture Analytical Services Laboratory.
The third goal of this project is Software Development. The goal will ensure that WDA/CHS can
work toward transitioning from the USAFS inspection system to the SAFHER inspection system.
WDA/CHS intends to work with partners at AFDO and other user group states to develop and
implement the SAFHER inspection program which will be replacing the USAFS inspection
system. This system will assist in integrating with other state and federal partners.
The fourth goal of this project is to continue offering outreach to our clientele. This goal allows
WDA/CHS to continue developing and producing guidance information and training for clientele.
WDA/CHS understands the importance of receiving feedback from stakeholders therefore, a
specific outcome of this goal is to implement a Food Protection Task Force to help direct the
work of the Manufactured Food Program.
All of the goals listed above are incorporated into the overall intention of this project, which is to
continue enhancing the Manufactured Food Regulatory Program Standards to ensure that the
WDA/CHS Manufactured Food Program is sustainable in the future. The desired outcome of
this would be to ensure that WDA/CHS is in full implementation and full conformance of each
standard and continually improve the state’s Manufactured Food Program. Each of these goals
plays a large part in ensuring that sustainability is reached.

Public health relevance
PROJECT NARRATIVE The project “Continued Enhancement of the WDA Manufactured Food Regulatory Program Standards to Ensure Sustainability” is designed to ensure that the Wyoming Department of Agriculture, Consumer Health Services (WDA/CHS) Manufactured Food Program continues to improve and be sustainable by using applicable practices and policies. Wyoming Department of Agriculture, Consumer Health Services intends to provide training to personnel; enhance program development to ensure food safety requirements are being met throughout the state; improve software to better equip inspection personnel; and provide outreach to industry to gain stakeholder input and advance the Manufactured Food Program. The ultimate desirable outcomes for this project would be for WDA/CHS to remain in full implementation and full conformance of all ten of the Manufactured Food Regulatory Program Standards (MFRPS) and continually improve the state’s Manufactured Food Program.